Enhancing Access for Successful Evaluation (EASE) Learning Experience

PROJECT SUMMARY
With the demand to train a diverse biomedical research workforce for a wide variety of research careers at an
all-time high, it is imperative that the biomedical research training programs that support these trainees be as
effective as possible. Rigorous and systematic program evaluation can help ensure that institutional training
programs are achieving the program’s intended outcomes. If programs are not identifying training goals when
creating their programing plans, it is unlikely they will be able to meet the needs of the defined outcomes, and
without measuring defined outcomes, it becomes impossible to quantify the effectiveness of the proposed
programming. Therefore, the emphasis of evidence-based program evaluation can support the creation of
more effective programs, as well as the dissemination of program aspects that are successful and could be
replicated elsewhere. Enhancing Access for Successful Evaluation (EASE) Learning Experience will support
and build evaluation capacity for institutions with biomedical research training programs and inform program
directors and administrators about effective and practical approaches to evaluate biomedical research training.
Intended learning goals will include the following: The proposed learning modules will: 1) Ensure that
biomedical training program administrators and investigators acquire a solid foundation of knowledge and
understanding of approaches to evaluate and measure the quality and effectiveness of biomedical training
programs. 2) Develop and enhance the technical skillset needed for rigorous evaluation of biomedical training
programs, which includes, but is not limited to evaluation planning, an introduction to quantitative, qualitative,
and mixed-methods data collection and analysis, and best practices and reporting and dissemination of
evaluation findings. 3) Enable biomedical training program administrators and investigators to apply the
knowledge and skills within diverse contexts for biomedical training program evaluations and across different
scientific domains or disciplines, through culturally responsive evaluation and assessment methods. We will
accomplish these learning goals through three specific aims. 1) Development of the EASE Learning
Experience content on supporting and building evaluation capacity for biomedical research training. 2) Conduct
a pilot of the EASE Learning Experience to assess the effectiveness of the modules and refine the modules
based on evaluation outcomes. 3) Broadly disseminate the EASE Learning Experience to the biomedical
research training community. The proposed EASE Learning Experience modules will aid in supporting
biomedical research training programs through program evaluation capacity building in order to ensure that
program directors and administrators have the knowledge and tools necessary to gauge program
effectiveness, relevance, and continuous improvement programming that will ultimately benefit program
trainees, institutions, and the broader scientific community.

Public health relevance
PROJECT NARRATIVE Evaluation of biomedical research training programs is a critical element to progress success and longevity. The proposed project will develop, test and disseminate modules aimed at increasing program evaluation knowledge and capacity for program directors and administrators across a broad spectrum of scientific disciplines.